Mentoring Oral Health Research in Louisiana

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To fund oral health research that ultimately may lead to new preventions, treatments and cures, as well as, potentially, savings in the health care system